Transcriptional control of collective cell migration

PROJECT SUMMARY / ABSTRACT Critical physiological and pathological processes, such as wound healing, de novo vessel angiogenesis and cancer metastasis, rely on directed collective cell migrations, whereby groups of cells become polarized and moves together in an orderly fashion. The ability of cell groups to migrate collectively is determined in part by the tissue-specific transcriptional inputs that define the complement of genes that they express and thus their competence to migrate. The long-term goal of this project is to understand how tissue-specific transcription regulators control the basic cellular processes underlying directed collective cell migration. To this aim, the simplified embryos of a chordate species, the ascidian Ciona intestinalis, will be used to study the migration of pre-cardiac mesoderm cells, called trunk ventral cells (TVCs). The TVCs provide the simplest possible model of directed collective cell migration in live embryos. On each side of the embryo, only two cells migrate together and display a clear Leader-Trailer (L-T) polarity aligned with the direction of migration: the leader TVC displays a broad leading edge and more conspicuous protrusions than the trailer. It was previously established that Mesp, Fibroblast Growth Factor (FGF) signaling and FoxF transcriptional inputs determine the ability of TVCs to migrate. The specific goal of the proposed research is to understand how transcriptional inputs contribute to the specification of the leader TVC and influence its protrusive activity. On the basis of preliminary observations, the hypotheses that (1) a ventral source of bone morphogenetic proteins (BMP) contributes to the L-T polarized expression of downstream target genes, including the Lef/Tcf transcription factor; and (2) these transcriptional inputs determine the L-T polarized activities of the Rho GTPases RhoDF and Cdc42, which are required for the formation of membrane protrusions will be tested. To address these possibilities, the expression, cis-regulation and function of Lef/Tcf in the TVCs will first be analyzed in order to understand L-T polarized transcriptional inputs. Second, quantitative imaging methods will be used to document the L-T polarization of RhoDF, Cdc42 and protrusive activities in wild-type conditions and after manipulations of transcription regulators and other candidate Rho GTPases in an attempt to characterize their effects on L-T polarized membrane protrusions. Finally, candidate regulated effectors of collective cell polarization and protrusive activity will be identified using TVC-specific whole genome microarray analysis followed by systematic expression and functional analyses by in situ hybridization and targeted over-expression, respectively. The expectation is to determine a mechanism of transcriptional control for collective cell migration by characterizing the transcription regulators, the regulated effectors and their effects on the Rho GTPase signaling and actin filament dynamics that underlie collective cell polarization and the formation of membrane protrusions.

Public health relevance
PROJECT NARRATIVE In animals, including humans, a variety of morphogenetic processes known as collective cell migrations are essential for physiological and pathological phenomena such as embryonic development, wound healing, de novo vessel formation and cancer metastasis. We propose to study the molecular and cellular mechanisms that control directed collective cell migration using the simplest possible model, which consists of two cells migrating as a polarized pair in embryos of the marine invertebrate, the tunicate Ciona intestinalis. Because of the evolutionary proximity with vertebrates, studies using this simple model will decipher the basic mechanisms driving collective cell migration with potential applications for regenerative medicine and the prevention of cancer metastasis. __SpecificAimsTextDelimiter__ SPECIFIC AIMS How tissue-specific gene regulatory networks govern developmental cell behavior during animal development remains poorly understood. We study this vast question using a simple chordate model system: the ascidian trunk ventral cells (TVCs), which constitute the precardiac mesoderm and migrate as a polarized pair of cells on each side of the embryo, thus representing the simplest possible model of directed collective cell migration. Our long-term goal is to build a quantitative system's view of TVC migration that will comprehend the gene regulatory networks' structure and transcriptional outputs, the full complement of regulated effector genes and sub-cellular processes underlying TVC migration. In this proposal, we focus our attention on the regulatory mechanisms that determine leader cell specification. Indeed, migrating pairs of TVCs are organized along the migratory axis with a leader TVC displaying a broad leading edge and more conspicuous membrane protrusions than the trailer TVC. Our previous studies indicate that transcriptional regulation by FGF signaling and FoxF controls the competence of TVCs to migrate and that both Leader-Trailer (L-T) polarity and membrane protrusions depend on the function of RhoDF and Cdc42 small guanosine triphosphatases (GTPases). Our preliminary observations suggest that an extrinsic ventral bone morphogenetic protein (BMP) signal determines the Leader-Trailer (L-T) polarized expression of downstream target genes, including the transcription factor Lef/Tcf. We will test the hypothesis that L-T polarized BMP and Lef/Tcf transcriptional inputs determine the TVCs' collective cell polarity in part through the regulation of RhoDF, Cdc42 and protrusive activities. In order to test this specific hypothesis, as well as refine our conceptual framework and further strengthen our expertise, we will address the following specific aims: Specific Aim1: Analyze the regulation and function of L-T polarized Lef/Tcf expression downstream of BMP signaling in the TVCs. (this specific aim focuses on the transcription regulators) 1.1. We will employ in situ hybridization and cis-regulatory analysis to characterize the L-T polarized expression Lef/Tcf in the TVCs and identify the cis-regulatory elements implicated. 1.2. We will analyze the L-T polarity of BMP signaling and its effects on the expression of Lef/Tcf in the TVCs. 1.3. We will use over-expression of wild-type and dominant negative mutant forms to characterize the function of Lef/Tcf during TVC migration. Specific Aim2: Characterize the effects of BMP signaling and Lef/Tcf on the L-T polarized formation of membrane protrusions and Rho GTPases activities in the TVCs. (this specific aim focuses on the sub-cellular processes) 2.1. We will use actin-filament binding GFP fusion proteins and FRET-based assays to visualize and quantify selected L-T polarized processes: the formation of membrane protrusions and the activation of the Rho GTPases RhoDF and Cdc42. 2.2. We will use targeted expression of constitutively active and dominant negative mutants for other Rho GTPases (RhoA, Rac1, Wrch and TC10) and use quantitative imaging assays to determine their effects on the above-mentioned selected L-T polarized processes. 2.3. We will use quantitative imaging assays to determine the effects of the TVC regulators (FGF signaling, FoxF), BMP signaling and Lef/Tcf on the selected L-T polarized processes. Specific Aim3. Identify and analyze candidate regulated effectors of L-T polarized protrusive activity (this specific aim focuses on the regulated effector genes) 3.1. We will use TVC-specific whole genome microarray analyses and systematic in situ hybridization to identify candidate effector genes for collective L-T polarization of the TVCs. 3.2. We will use targeted over-expression to obtain initial functional information on the candidate L-T polarized effectors. We expect that completion of the proposed research will provide mechanistic insights into the transcription control of the cellular effectors and sub-cellular processes underlying collective cell polarization, with potential consequence for the understanding of similar morphogenetic events at work during physiological and pathological processes such as wound healing, angiogenesis and cancer metastasis.